Leadership and Administrative Core

ASCENT: LEADERSHIP AND ADMINISTRATIVE CORE (LAC) PROJECT SUMMARY/ABSTRACT
The mission of the Advancing the Science of Palliative Care Research Across the Lifespan (ASCENT)
Consortium is to develop and support a nationwide palliative care (PC) scientific workforce who will perform
innovative, interdisciplinary PC research to improve care for persons with serious illness (PWSI) and their
families across the lifespan, including those living with cancer or Alzheimer’s Disease and Alzheimer’s
Disease Related Dementias (AD/ADRD). To achieve this mission requires a complex, innovative, and agile
governance structure to meet the goals set out by the ASCENT Consortium and the National Institutes of
Health. The Leadership and Administrative Core (LAC) holds the key responsibility for ensuring effective and
efficient leadership to govern and integrate all aspects of the ASCENT Consortium. The Specific Aims of
the LAC are to: Aim 1: Lead the governance, administration, and integration of all ASCENT Consortium
components. Aim 2: Support the generation of high-quality PC research and research methodologies across
the lifespan. Aim 3: Build and sustain an infrastructure to: Aim 3a. Support the palliative care community in
conducting high-quality research across the lifespan. Aim 3b. Implement strategies to foster engagement
with and access to Consortium Cores, activities and resources. Aim 4: Provide the infrastructure to support
the dissemination of new PC knowledge to practice settings, the research community, and policy makers to
advance the delivery of PC to PWSI and their caregivers. To achieve these aims, the LAC will synergistically
integrate the cores and programs of the ASCENT Consortium to support building a community of PC
researchers and high-quality, PC research across the lifespan. The LAC will operationalize this integration
through 5 hubs: 1. Administration, Regulatory, and Finance, 2. Scientific Consultation & Research
Resources, 3. Grants Programs and Training, 4. Lifespan, and 5. Engagement. A highly accomplished
investigational and operational team will lead these hubs, collaborating to accomplish the aims of the LAC
and ensure success of the overall ASCENT consortium.